Acute and Chronic Social Stressors on Daily Associations and Long-Term Health Trajectories among Filipino, Korean, and Indian Americans

Given the substantial variation within and across Asian American subgroups, there is
compelling evidence that distinct developmental trajectories may exist for health outcomes
such as substance use (e.g., alcohol, tobacco, marijuana), mental health, and physical
health. This proposed study will be one of the first to investigate latent class trajectories
of these outcomes among U.S.-born Filipino, Korean, and Indian American young adults,
aged 18–19. We will examine how acute and chronic social stressors are prospectively
associated with patterns of alcohol and drug use, psychological distress, and somatic
health over a 36-month period. This work will offer novel insights into the longitudinal
impact of social stressors and will help elucidate the developmental course and cooccurrence
of multiple health challenges. Findings have the potential to inform more
nuanced theoretical models of health risk among these three Asian American groups.

Public health relevance
Asian American groups vary widely in background and health outcomes, yet little is known about how these differences influence the development of substance use, mental health, and physical health problems. This study will be one of the first to track health trajectories among U.S.-born Filipino, Korean, and Indian American young adults starting at ages 18– 19. By examining how acute and chronic stressors shape these outcomes over time, the study will help identify early risk factors and inform more effective prevention efforts.